Purinergic Signaling in Intestinal Inflammation

PROJECT SUMMARY
Purines are important signaling molecules that influence multiple pathways in the human body by activating
purinergic receptors on target cells. Recent research has identified that purines and their corresponding
purinergic receptors play critical roles in infectious disease. However, much of this research has focused on
purinergic signaling within immune cells and the enteric nervous system, leaving the role of epithelial cells in the
gastrointestinal tract largely unexplored. Our group has identified that the purinergic receptor P2Y1 is highly
expressed in the human intestine and in human intestinal organoids. We found that activation of P2Y1 stimulates
robust calcium signaling and cell-cell communication; pathways known to be involved in epithelial responses to
injury. We generated CRISPR-Cas9 knockout (KO) organoids of P2Y1 and found that these cells had reduced
calcium signaling and decreased wound closure rate. We also generated epithelial specific P2Y1 KO
(VillinCre:P2Y1flox/flox) mice and found that these P2Y1 KO animals were more susceptible to dextran sodium
sulfate (DSS) induced colitis. Both our organoid and animal models suggest that P2Y1 is critical for proper
intestinal wound healing and response to injury. Finally, we found Ulcerative Colitis patients with active
inflammation have a significant reduction in P2Y1 expression, but P2Y1 expression returns to normal when
grown as organoids and removed from the inflammatory environment. These data suggest that P2Y1 is
influenced by inflammatory signals and maybe a target for promoting wound repair in the inflamed gut. Our
central hypothesis is that epithelial purinergic P2Y1 signaling is involved in intestinal inflammation
during colitis and plays an important role in repair. The objective of this research is to elucidate the role of
epithelial purinergic signaling in intestinal inflammation and the mechanistic consequences of these pathways.
Aim 1 will delineate the role of epithelial P2Y1 purinergic signaling in vivo during acute and chronic colitis and
wound biopsy punch. We anticipate that deficiency of P2Y1 (Villincre:P2Y1flox/flox mice) will result in worsened DSS
and T-cell transfer induced colitis and delayed healing compared to WT mice. In Aim 2 we will identify the
mechanism by which P2Y1 signaling drives wound healing and determine how inflammatory signals affect P2Y1
signaling pathways using human colonic organoids derived from healthy and ulcerative colitis patients. We
anticipate P2Y1 activates both proliferative (ERK1/2) and cell migration (Itpkb) pathways to promote proper
repair following injury. However, in the presence of pro-inflammatory stimuli, we postulate that P2Y1 expression
and its downstream signaling pathways will be downregulated. This study will provide evidence for the
importance of P2Y1 purinergic signaling in epithelial cells in the context of intestinal inflammation during colitis.
Collectively, these experiments will advance our understanding of intestinal inflammation and may unveil
potential novel therapeutic targets.

Public health relevance
PROJECT NARRATIVE Purinergic signaling plays a key role in cell-cell communication and our preliminary data shows that deficiency of the epithelial P2Y1 purinergic receptor results in delayed healing and worsened colitis. During colitis, extracellular purines are known to be increased, but the contribution and mechanism of epithelial purinergic signaling in these models remain unknown. This proposal seeks to elucidate the role of purinergic signaling via P2Y1 during intestinal inflammation in the setting of acute and chronic colitis and injury, with the aim to provide new targets to minimize tissue damage.